Project 2: Microenvironmental and inflammatory mechanisms in MDM4-driven AML pathogenesis.

Project Summary/Abstract
Recent studies have demonstrated the existence of preleukemic (preL) HSPC (which includes the
phenomenon of age-related clonal hematopoiesis (ARCH)) in human MDS and AML. In the majority
of patients, the disease clone occurring at relapse/progression is not directly derived from the
initially transformed LSC clone through the acquisition of additional mutations, but is rather arising
from preexisting preL-HSPC clones. These observations have fundamentally challenged the
classical model of linear-divergent tumor progression, and indicate that heterogeneous
preleukemic cell states early in the transformation process hold the key for understanding the
origin of tumor heterogeneity, stem cell subclonal dynamics, competition and selection, and
progression and death of patients. We have previously discovered that mouse/human double
minute 4 (MDM4/HDM4; synonym: MDMX/HDMX) is significantly overexpressed in the vast
majority of patients with AML, including at the stem cell level. Elevated MDM4 expands and
increases competitiveness of preL HSPC, promotes ARCH/MDS-to-AML progression in several
newly developed mouse models, and patient data indicates that MDM4high MDS patients are at
significantly higher risk to progress to AML. For this project, and based on published and newer
preliminary data, we hypothesize that MDM4 overexpression acts in ARCH/MDS-to-AML
progression in the context of microenvironmental changes and selection pressures that are
frequently encountered during aging and inflammatory stress. Preliminary data imply specifically
the βcat/Cnot6l axis as well as IL-1 signaling in the progression of Mdm4high ARCH/MDS to AML. We
will determine the role of stromal and inflammatory changes in selection, expansion, and
progression of the MDM4high pre-leukemic stem cell pool; identify and functionally characterize
molecular mechanisms employed by the stroma and inflammatory stress that mediate MDM4-
dependent progression of ARCH and MDS, using a combination of CITE-seq, subclonal tracking,
spatial mapping, and analysis of select targets on longitudinal samples during progression; and,
examine whether preemptive combinatorial targeting of the MDM4/TP53 interaction and cell
extrinsically-driven pathways can prevent progression of ARCH and MDS by testing clinically
available inhibitors of MDM4/TP53, combined with either genetic or pharmacologic targeting of
identified stromal and inflammatory pathways. These studies will provide novel mechanistic
insights into combinatorial cell-intrinsic/extrinsic preleukemic to AML progression as well as a
preclinical proof-of-concept for the design of preventative clinical trials in the future.

Public health relevance
Project 2: Microenvironmental and inflammatory mechanisms in MDM4-driven AML pathogenesis. Project Leader: Ulrich Steidl Project Narrative We hypothesize that MDM4 overexpression acts in ARCH/MDS-to-AML progression in the context of microenvironmental changes and selection pressures that are frequently encountered during aging and inflammatory stress. Our studies will provide novel mechanistic insights into combinatorial cell-intrinsic/extrinsic preleukemic to AML progression as well as a preclinical proof- of-concept for the design of preventative clinical trials in the future.